It's a tug of war: structure, consequences, and inhibition of CXCR4 and ACKR3 responses to lymphocyte chemoattractant CXCL12

The G protein-coupled chemokine receptor, CXCR4, and the atypical chemokine receptor, ACKR3, play critical
roles in cell migration during immune responses and organ development, through coordinated responses to a
shared ligand, CXCL12. Both receptors contribute to numerous inflammatory and autoimmune diseases and are
under active investigation as therapeutic targets. Nevertheless, there is currently only one FDA-approved
CXCR4 antagonist (AMD3100/Plerixafor), and its use is limited to mobilizing hematopoietic stem cells for bone
marrow transplants, because many of its properties are suboptimal. Therapeutic targeting of ACKR3 is at a less
mature stage than CXCR4; in fact, most known compounds are agonists, and it is unclear how to antagonize
this receptor. Improved compounds targeting both CXCR4 and ACKR3 are therefore needed.
As an "atypical" receptor, ACKR3 is widely assumed to function only through β-arrestin (and not G proteins), and
is best known for its ability to “scavenge” CXCL12 from the extracellular environment. By doing so, ACKR3
prevents downregulation of CXCR4 and maintains its responsiveness to CXCL12 gradients. When co-expressed
in the same cell, ACKR3 can also alter CXCR4 signaling and trafficking via heterodimerization, sequestration of
β-arrestin, and other as-yet-undeciphered mechanisms. Given that ACKR3 binds CXCL12 in an architecture
similar to CXCR4, undergoes similar conformational changes upon activation, and shares all of the conserved
G protein-coupling determinants, its presumed Gi incompetency is striking. Even more striking is the exceptional
robustness of ACKR3 activation to ligand and receptor modifications, whereas CXCR4 activation is abrogated
by the subtlest of such changes. Because of this activation-prone nature, most non-chemokine (and even small
molecule) ligands activate ACKR3 association with β-arrestin, with unknown downstream consequences.
Despite the role of the two receptors in disease, the structural and molecular mechanisms underlying their
individual functions and their cellular crosstalk remain elusive. In this MPI proposal, the Handel and Kufareva
labs combine their experimental and computational expertise, respectively, with their in-depth knowledge of
chemokine receptors, to explain the distinct activation mechanisms of CXCR4 (Aim 1) and ACKR3 (Aim 2) from
the standpoint of structure and dynamics, to understand how to inhibit these receptors (Aims 1 and 2), and to
understand how ACKR3 regulates the function of CXCR4 (Aim 3). To achieve these aims, specific mechanistic
hypotheses are probed with a combination of structural (cryo-EM and crystallography), computational (modeling
and MD) and cell-based functional experiments, and complemented by unbiased discovery proteomics. These
studies will deliver unprecedented insight into the function of CXCR4 and ACKR3, which will have a direct impact
on the development of small molecule therapeutics and provide the rationale for blocking one or both receptors.
By revealing general principles, the proposed studies will also advance the understanding and targeting of other
therapeutically important chemokine receptors, which are considered challenging targets.

Public health relevance
Chemokine receptors CXCR4 and ACKR3 play critical roles in cell migration during immune responses, organ development and homing of hematopoietic stem cells, through coordinated responses to a shared ligand, the chemoattractant CXCL12. Although they are promising drug targets, the structural mechanisms underlying their individual functions and their cellular crosstalk is poorly understood. The proposed studies will reveal general principles of CXCR4 and ACKR3 activation, inhibition, and functional interplay, which will inform strategies for the development of single or combination CXCR4/ACKR3 therapies.